FLOW EFFECTS OF ENDOTHELIAL/TROPHOBLAST INTERACTION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. This research attempts to understand how the migration of placental trophoblast cells is regulated by the effects of blood flow. The work is intended to uncover new regulatory pathways that could be disrupted in pregnancy disorders such as preeclampsia. These findings could therefore lead to improved diagnosis and treatment of these disorders.